Perioperative Diffuse Optical Imaging of Tissue Blood Flow and Oxygenation for Optimization of Mastectomy Skin Flap Viability

ABSTRACT
Mastectomy is performed on approximately half of women with breast cancer. Postmastectomy breast
reconstruction has benefits for body image, sexuality, self-esteem, and quality of life. Poor clinical prognoses
after breast reconstruction often involve mastectomy skin flap necrosis (MSFN) or other complications
associated with the lack of blood flow and oxygenation to wound tissue volumes. MSFN and wound dehiscence
leads to a number of challenges, including wound management problems, delays to adjuvant therapy, esthetic
compromise, implant extrusion, patient distress, and financial loss. A technology that allows surgeons to
perioperatively assess and optimize preservation of skin flaps while avoiding complications is essential to ensure
successful clinical outcomes. Although alternative techniques have been explored to identify ischemic-hypoxic
tissues at risk of necrosis, none have achieved universal acceptance as each technique has a few challenging
issues that decrease its clinical usefulness. Moreover, no single technique provides both blood flow and
oxygenation information, which are essential for precise assessment of skin flap viability. Our recent innovative
development of near-infrared speckle contrast diffuse correlation tomography (scDCT) technique provides a
noninvasive (dye-free) and noncontact means for continuous 2D/3D imaging of blood flow distributions
throughout large/thick tissue volumes such as mastectomy skin flaps. We propose to extend this scDCT
prototype to a next generation multi-wavelength scDCT (MW-scDCT) device for perioperative imaging of both
blood flow and oxygenation distributions in mastectomy skin flaps. New high-speed algorithms for 2D mapping
and 3D image reconstruction will be developed to accommodate rapid online assessment of skin flap
hemodynamics. This MW-scDCT system will be tested/optimized using standard tissue-simulating phantoms
(Aim 1) and calibrated/validated against a commercial dye-based fluorescence angiography device (SPY Elite®)
in swine (Aim 2) and patients (Aim 3) undergoing mastectomy with expander-implant based breast
reconstruction. The in vivo studies will determine the capability of our MW-scDCT for intraoperative prediction of
MSFN regions/volumes and postoperative optimization of incremental expander volumes to reduce risks of
MSFN and other complications. We expect that combined measurements of preoperative baseline and
intraoperative alteration in skin flap flow and oxygenation will provide a more accurate assessment of skin flap
viability than a one-time single-parameter measurement (i.e., blood flow, blood oxygenation, or fluorescence
perfusion). Study outcomes will provide the rationale for designing MW-scDCT guided clinical trials of
mastectomy with breast reconstruction to reduce postoperative complications and healthcare costs. Moreover,
this noninvasive (dye-free), noncontact, continuous, and cost-efficient imaging system has the potential for
perioperative use in many other clinical settings, especially where contact measurements may not be possible,
such as for continual and longitudinal monitoring of burns, wounds, and other types of tissue flaps.

Public health relevance
PROJECT NARRATIVE Clinical prognoses after surgical breast reconstruction often involve mastectomy skin flap necrosis or other complications associated with lack of blood flow and oxygenation to wound tissue volumes. The objective of this project is to design and optimize a novel noninvasive optical imaging technique, which will enable rapid online 3D imaging of both blood flow and oxygenation distributions throughout the entire volume of mastectomy skin flaps to perioperatively assess ischemic-hypoxic tissue regions/volumes. Outcomes from this translational study in swine and patients undergoing mastectomy with expander-implant based breast reconstruction will provide essential information for intraoperative guidance of compromised tissue excision and postoperative optimization of incremental expander fill volumes to reduce postmastectomy complications and healthcare costs.